Novel CAR T cell engineering strategies for effective eradication of solid and liquid tumors

PROJECT SUMMARY
CAR T cell therapy has revolutionized the treatment of B cell malignancies but has yet to reach its full potential
for patients with other tumor types, patients who are initially resistant, or patients who relapse following treatment.
CAR T cells are hindered by a lack of tumor-specific antigens that are safe to target and/or homogenously
expressed throughout the tumor and limited T cell persistence. To address these challenges during our previous
award, we developed and optimized a new CAR T cell platform to express the CAR along with a T cell-engaging
antibody molecule (TEAM) that targets a second antigen while engaging T cells (CAR and non-CAR) within the
tumor. We used this platform to boost the killing of heterogeneous glioblastoma (GBM) tumors, prevent antigen
escape in acute myeloid leukemia (AML), and target the tumor and suppressive tumor microenvironment in
pancreatic cancer, in relevant preclinical models. We also used a genome-wide CRISPR screen in
heterogeneous GBM tumors to determine cancer cell-intrinsic mechanisms of resistance to CAR T cells. We
identified CAR T cell adhesion to the tumor cell as imperative for effective CAR T cell killing. Finally, we leveraged
our CRISPR screening experience to perform an in vivo CRISPR screen in CAR T cells to identify genes that,
when knocked out, increase CAR T cell persistence in models of pancreatic cancer and multiple myeloma.
Building on the knowledge gained during the previous award period, we plan to further improve CAR T cell
targeting of tumor cells by increasing their adhesion and using CRISPR editing to prolong persistence. We will
accomplish these goals using novel engineering strategies to (1) modify our CAR-TEAM system to secrete
engagers that target a 2nd tumor antigen while also increasing adhesion to tumor cells in models of GBM and
lymphoma, (2) validate the results of our in vivo screens in their original tumor models (pancreatic cancer or
multiple myeloma) and apply these gene KOs to other tumor types with similar solid vs. liquid histologies (GBM
and lymphoma), and (3) combine these methods to create CAR T cells that secrete adhesion-enhancing
engagers and have genetic KOs to increase persistence. We hypothesize that combining these approaches will
create the best possible CAR T cells for overcoming the resistance mechanisms that are specific to the biology
dictating how CAR T cells interact with different tumors.
Overall, through rigorous preclinical testing during this award, we will identify CAR T cell engineering strategies
for future translation to phase I clinical trials, as we have already done with the CAR-TEAM platforms developed
during our previous award. Collectively, the results of the proposed projects will inform the optimal CAR T cell
designs to target varying tumor types and make CAR T cell therapy more broadly applicable across patients.

Public health relevance
PROJECT NARRATIVE Chimeric antigen receptor (CAR) T cells are a cancer therapy that reprograms patient immune cells to kill cancer cells. They have cured many blood cancer patients but require optimization to effectively treat patients who are initially resistant to this therapy or have other tumor types. We will use novel engineering strategies to improve CAR T cell function and make them effective for these patients.